Feasibility of Microsoft Kinect for Assessment of Independent Wheelchair Transfers

DESCRIPTION (provided by applicant): Transfers are an essential task performed numerous times a day by wheelchair users with lower limb paralysis or dysfunction. Because transfers are highly physically demanding on the upper limbs they are a major contributor to the development of upper limb pain and injury. In previous work, we developed an instrumented transfer station to evaluate the biomechanics of sitting-pivot wheelchair transfer techniques. We discovered that using certain prescribed trunk and hand positions reduces loading on the upper limb joints. We also developed and established the psychometric properties of the Transfer Assessment Instrument (TAI) which is a quick and easy way that clinicians can determine how well their patients adhere to best transfer practices. We found that subjects who had TAI detectable technique deficits and received individualized training by a therapist to correct these deficits showed an immediate improvement in their movement patterns and forces after the training session. While one-on-one training with a therapist is ideal, the training is labor intensive. Moreover, shorter rehab stays and heavy caseloads prohibit clinicians from spending a lot of time teaching and reinforcing transfer skills. Once taught, patients are generally responsible for practicing and implementing the techniques on their own. Supplementing the clinician's training with an interactive coaching tool that provides veterans with a way to check and correct their form on their own would likely facilitate the learning and retention of new transfer skills. This pre-development phase of research will determine the types of transfer movement variables that can be reliability detected with the Microsoft KinectTM, a low-cost, markerless motion capture system and the accuracy associated with each movement variable. Aim 1 will be to identify Kinect motions that are reliable and consistent with motions measured by a reference 3D marker based system (e.g. Vicon). Twenty-five wheelchair users who are independent with transfers will transfer to/from two surfaces (e.g. a level bench and commode) while the two systems simultaneously record their movement patterns. We hypothesize that the 3D trunk, shoulder, elbow and wrist angle motions measured with the Kinect will follow a similar trajectory as the Vicon-measured motions and the peak angles will be repeatable and similar between the two systems. Aim 2 will evaluate an additional 25 subjects to explore the relationships between TAI scores and Kinect motions during transfers. We hypothesize that Kinect motions will be significantly correlated with the quality of the transfers. Successful completion of this study will allow for defining the design criteria and features of the transfer coaching system.

Public health relevance
PUBLIC HEALTH RELEVANCE: For wheelchair users, transfers are crucial for independence in activities of daily living however they carry great risk to developing overuse related shoulder pain and injuries due to the repetitious and high force nature of the task. Recent research has shown that technique influences the amount of force imparted on the upper limbs. However, the resources and tools to assess technique and to teach veterans how to perform better transfers are lacking. One-on-one training with a therapist is short-term, may not be available to all veterans and requires that the therapist be present, educated on best practices and have the time to teach transfer skills in busy rehab settings. The proposed project will examine the feasibility of using the Microsoft Kinect to track transfer motions and support the future development of a low-cost interactive tool that could be used to help veterans learn how to execute less-injurious transfer techniques.